Dynamics of calcium signals control neurotransmitter release in retinal ribbon synapses

Retinal bipolar cells are the first 'projection neurons' of the vertebrate visual system and transmit all of the
information needed for vision. Bipolar cells can signal change in contrast while providing an analog read-out of
luminance via changing the rate of neurotransmitter release (NTR). To maintain this ability, the bipolar cells must
have dynamic control over release rate and the efficient recruitment of release-ready vesicles to fusion sites.
However, the spatiotemporal properties of Ca2+ signals that control NTR, and the molecular entities that control
the interplay between Ca2+ signal and vesicle dynamics in sustaining kinetically distinct NTR components remain
poorly understood. The long-term goal is to unveil the regulation of Ca2+ signaling in retinal ribbon synapses
during development, normal adulthood, and disease. Within such goal, the overall objective of this proposal is to
determine the spatiotemporal properties of Ca2+ signals that control kinetically distinct pools of NTR and the role
of local Ca2+ signals in governing vesicle dynamics that sustain neurotransmission in bipolar cell ribbon
synapses. The central hypothesis is that Ca2+ domains governing kinetically distinct components of NTR are
different because the ribbon itself adds an additional compartment responsible for spatial segregation of
kinetically different synaptic vesicles, and the underlying molecular targets that sense Ca2+ concentration and/or
alter Ca2+ signals. This hypothesis is based on preliminary data, acquired in applicant's laboratory using novel
techniques developed for evaluating the traffic of single synaptic vesicles at ribbons while simultaneously
measuring the underlying changes in [Ca2+], all with millisecond temporal precision. This hypothesis will be tested
by pursuing two specific aims using a confluence of state-of-the-art fluorescence imaging, voltage-clamp
electrophysiology, computational modeling, electron microscopy of individual physiologically identified cells, and
pharmacological tools: 1) Reveal the mechanisms that determine the spatiotemporal properties of calcium
signals which control kinetically distinct neurotransmitter release pools; and 2) Determine the interplay between
local calcium signaling and vesicle replenishment that is required for sustaining kinetically distinct components
of NTR in rod bipolar cell ribbon synapses as a model system. Dysregulation of Ca2+ signaling is a key early–
stage process of neurodegeneration in age-related retinal degenerations, glaucoma, diabetic, and optic
neuropathies. The knowledge gained from studying Ca2+ dynamics in bipolar cell synaptic transmission will allow
us to determine if defects with local Ca2+ homeostasis are a prelude to disease in the future. Data generated
from this proposal will have a broad impact that extends beyond our specific investigation of rod bipolar cells but
will be applicable to similar ribbon synapses located within and outside the visual system and encoding distinct
aspects of sensory information and, more widely, to synapses throughout the central nervous system because
the CAZ of ribbon synapses shares many molecular components with conventional synapses.

Public health relevance
Narrative (Request for an administrative supplement): The overall purpose of this request for an administrative supplement is to purchase multiphoton to complete and expedite the projects described in our R01 funded. The confocal system is currently shared by three people, which is not productive because each experiment can take up to 10-12 hours to complete. In addition, for our currently funded projects (SA1, Exp#4), it is vital to extend our findings from an isolated neuron into a retinal slice of zebrafish retina, and SA1, Exp#7 must be conducted in the dark-adapted state to prevent disrupting the diurnal changes in the ribbon, which require an upright multiphoton to obtain these measurements.